DCS cerebral blood flow monitor for extreme low-birth-weight infants

PROJECT SUMMARY/ABSTRACT
Every year in the United States about 30% of the 60,000 infants born extremely premature (<30 weeks
gestational age and <1000 g birth-weight [ELGA]) develop intraventricular hemorrhage (IVH). IVH is
associated with high risk for cerebral palsy and significant intellectual disability, causing lifelong implications for
affected children and their families and considerable economic burden. IVH is caused by the rupture of the
fragile capillaries in the germinal matrix which cannot withstand fluctuations in cerebral blood flow (CBF). In
>90% of cases, these injuries occur during the first three postnatal days during a period of cardiorespiratory
instability that has a direct effect on CBF, which results in periods of cerebral hypo- and hyper-perfusion.
Current management strategies, such as changes in ventilation or inotrope support, are blind to the impact on
CBF. Improved bedside technologies to continuously monitor CBF are urgently needed to allow the clinician to
make informed decisions, to optimize current strategies and foster the development of new interventions to
reduce the incidence of IVH in ELGA infants and to improve developmental outcomes. Building on our ten
years of success measuring infants with non-invasive bedside optical methods, we propose to design and build
a novel fast, three-wavelength, five-distances diffuse correlation spectroscopy (DCS) system, optimized for
continuous monitoring of CBFi in ELGA infants. DCS directly quantifies an index of cerebral blood flow (CBFi)
by measuring the temporal fluctuations of light generated by the dynamic scattering of moving red blood cells.
To be of use in the ELGA infant, this bedside monitor needs to be safe, continuous, precise, reliable,
quantitative and gently wearable. These pre-requisites will be met by designing an optical sensor which can be
gently applied to the ELGA infant. The device will adopt a novel multi-distance, multi-wavelength method to
assess tissue scattering and absorption coefficients, which are needed in combination with autocorrelation
decay rates to correctly quantify CBFi. The novel DCS system will be initially tested by the Massachusetts
General Hospital (MGH) team in phantoms to verify performance and demonstrate precision and accuracy of
flow estimates. The system will then be tested in more mature, stable premature infants at the Brigham and
Women's Hospital (BWH) NICU to evaluate feasibility of long measurements, compatibility with the NICU
environment, skin integrity after long monitoring periods, and in-vivo algorithm validation. Finally, the device
will be used in 100 ELGA infants during the first 72 hours of life to test our hypothesis that DCS-measured
CBFi fluctuations and pressure-passive events correlate with incidence and severity of IVH. Our goal is to
provide a much-needed cerebral blood flow monitor to guide individualized treatment with the goal of reducing
the risk of IVH and improving long term neurodevelopmental outcomes among ELGA infants. This study in 100
ELGA infants will set the stage for a larger trial alongside commercialization.

Public health relevance
PROJECT NARRATIVE There is a great need for a bedside, non- invasive and continuous neuromonitoring tool to provide a robust measure of cerebral blood flow in premature infants. We propose to develop a novel diffuse correlation spectroscopy (DCS) system optimized for quantitative monitoring of cerebral blood flow index in extremely premature infants. The successful development, validation and demonstration of clinical feasibility and effectiveness of our proposed technology will lead to new patient management approaches for reducing neurological injury, protecting neurocognitive function, and reducing the overall morbidity and mortality associated with prematurity.